Harnessing Health Data Science capacity to strengthen evidence-based interventions, policy and response to the HIV/AIDS Epidemic in Uganda (H-DATA)

PROJECT SUMMARY
This is an application for the D43: Fogarty HIV Research Training Program for Low-and Middle-Income Country
Institutions PAR-22-151. The proposed grant’s goal is to leverage on the existing partnership between Makerere
University and University of California San Francisco to equip Ugandan scientists and healthcare practitioners
with health data science practical skills to advance the use of data to prevent, treat, and ultimately cure HIV/AIDS
in Uganda. Cognizant of the fact that, the use of data science analytics in medicine is already generating new
knowledge that is advancing prediction, performance and discovery in health, the training program aims to; (1)
Strengthen the scientific leadership and expertise needed for health data science research with increased focus
on long term graduate (PhDd and Msc) training in health data science. (2) Train MakCHS faculty to enhance
their capabilities for Health data science research and mentorship of health data science trainees. (3)
To strengthen trainee contributions to evidence–based decision making related to HIV prevention,
care and treatment services through regular interactions with policy makers and HIV program implementers. The
training program will consist of PhD, masters, and faculty trainees with specific short course trainings on
Fundamentals of Health Data Science, Digital Medicine, Introduction to Artificial Intelligence, Applied Machine
Learning, Statistical Methods & Data Analysis, Bio-Python, Programming with Java, R & Bio-Conductor, Discrete
Mathematics, Algorithms for Health Data Science, Data Mining Visualization for Healthcare, Scientific Writing &
Grantsmanship.

Public health relevance
PROJECT NARRATIVE HIV/AIDS remains a significant health challenge in Uganda and other SSA countries. With current efforts to scale up HIV treatment before severe immune suppression, there is need to understand complexities related to early ART initiation e.g., issues of long-term adherence, clinical and immunological treatment outcomes, HIV-associated malignancies and antimicrobial resistance (AMR). Addressing these will require a new thinking and approaches for generating and synthesizing evidence that can inform policy. Research training in LICs provides an avenue to build capacity for locally generated investigations aimed at preventing and controlling HIV/AIDS. Leveraging on existing infrastructure at Makerere University College of Sciences and international collaboration with University of California San Francisco, we propose a plan for a comprehensive multi-disciplinary health data science research-training program in Uganda.